Continued support for an SPF Macaca nemestrina breeding colony to provide animals to NIH funded HIV research projects

Abstract
The aims of this project are to provide healthy, behaviorally normal, MHC-characterized, SPF pig-tailed
macaques for NIH-funded HIV/AIDS related research. We will expand the size of the current SPF breeding
colony to increase the numbers of females for breeding and juvenile males and females available for sale to
NIH-funded HIV/AIDS investigators both within Johns Hopkins University and at other research institutions.
Complete pedigrees and health data are maintained and provided to investigators when animals are being
selected for sale. Viral screening includes regular serologic and PCR testing for 4 viral agents: Cercopithecine
herpesvirus 1 (B virus), Simian Immunodeficiency Virus (SIV), Simian Retrovirus (SRV), and Simian T-
lymphotrophic Virus (STLV). For the past decade the colony has consistently and repeatedly tested negative
for these agents. Major histocompatibility (MHC) profiles are performed on all juveniles during the first year of
life and are provided to investigators when animals are being selected for purchase. Over the last five years,
the colony has produced an average of 51 offspring each year, resulting in an average of 32 animals sold. We
estimate that selling 42 animals per year would allow the colony to achieve self-sufficiency, a goal we project
we will reach by the end of 2028.

Public health relevance
Project Narrative This renewal of our Cooperative Agreement (U42OD013117) requests four years of funding to continue support for a Specific Pathogen Free (SPF) colony of healthy, behaviorally normal, major histocompatibility complex (MHC) profiled pig-tailed macaques (Macaca nemestrina) at the Johns Hopkins University. Since 2016, our colony has produced an average of 51 offspring each year and we have sold an average of 32. At least 50% of colony-produced juvenile males, and increasing numbers of juvenile females, are sold to NIH- funded investigators outside of Johns Hopkins for HIV/AIDS related research, demonstrating the colony's status as a national resource.